Endocrine tissue molecular pathways dysregulated by immune checkpoint inhibitors causing ICI-triggered adverse events

Project Summary/Abstract
Programed death ligand-1 (PD‐L1) is an immune checkpoint inhibitor (ICI) that interacts with its receptor,
programmed death‐1 (PD‐1) to inhibit T‐cell activation. Cancer cells adapted to manipulate this mechanism, by
overexpressing PD-L1 to evade immune activation and attack. Therefore, abrogation of PD-L1/PD-1 interaction
by monoclonal antibodies (MAb’s) is an effective therapeutic strategy for several cancers. However, it is
complicated by immune related adverse events (irAEs), including endocrine AEs (eAEs). Thyroid dysfunction,
including destructive thyroiditis and hypothyroidism, are the most common eAEs associated with PD-L1/PD-1
blockade, affecting up to 21% of patients. Because their mechanisms are not known, currently these conditions
are treated symptomatically and as a result, patients are often difficult to manage, and the eAEs can interfere
with the cancer treatment. Therefore, new therapies are needed that target the mechanisms causing eAEs. We
have found that PD-L1, expressed in the thyroid, exerts intrinsic functions in thyroid cells. We have generated
human thyroid cell lines with either downregulated or increased PD-L1 expression and demonstrated that PD-
L1 engages cell survival mechanisms in response to inflammatory cytokine-induced stress. Suppression of PD-
L1 in thyroid cells rendered them more susceptible to cellular stress and apoptosis induced by inflammatory
cytokines. The intrinsic functions of PD-L1 in thyrocytes and their role in the development of ICI thyroiditis have
not been studied before. In this proposal we will dissect the immune-independent functions of PD-L1 in thyroid
cells and their role in the development of ICI-thyroiditis. Our hypothesis is that blockade of PD-L1 in thyroid cells
through anti-PD-L1 therapies, triggers dysregulation of pro-survival intracellular signals controlled by PD-L1,
rendering thyrocytes vulnerable to cytokine mediated destruction. In Aim 1 we will perform cellular and molecular
studies in thyroid cell lines with upregulated and downregulated PD-L1 expression to dissect the intracellular
functions of PD-L1 by assessing: (1) Molecular mediators of PD-L1 intrinsic activity (e.g., signals delivered
through the PD-L1 intracytoplasmic domain); (2) The role of PD-L1 in cellular responses to inflammatory stress;
and (3) The downstream effectors of PD-L1 activity. In Aim 2 we will use a new mouse model of anti-PD-L1
induced thyroiditis we developed to test: (1) How inflammatory cytokines affect the development of anti-PD-L1
induced thyroiditis; and (2) The possibility of reversing/suppressing thyroiditis in this mouse model by restoring
autophagy in thyroid cells. In summary, we are proposing a “two-hit” model for ICI thyroiditis whereby PD-
L1 blockade triggers both: (1) Activation of intra-thyroidal T-cells & inflammatory cytokine secretion; and (2)
Dysregulation of thyrocyte intra-cellular signals making them susceptible to inflammatory cytokine damage. In
this proposal we will dissect the nonimmune roles for PD-L1 in thyroid cells and extend the understating of the
“off-target” effects of anti-PD-L1 immunotherapy. Our studies will hopefully help design targeted mechanism-
based therapies for ICI associated adverse events in the thyroid and other organs.

Public health relevance
PROJECT NARATIVE Our proposal aims to analyze the mechanisms by which immune therapies for cancer (checkpoint inhibitors) cause thyroid disease. Our focus is on the intrinsic functions of the checkpoint molecule, PD-L1, in the thyroid, and how blocking it causes thyroid cell stress and thyroiditis. These studies will identify the mechanisms by which checkpoint inhibitors cause thyroiditis and will hopefully help in the development of novel therapies.